Aza-Heck/C-C cleavage/cross coupling cascades of pinene derivatives for the synthesis of zoanthamine alkaloids

PROJECT SUMMARY/ABSTRACT
Nitrogen-containing heterocycles are of considerable interest in medicinal chemistry, often responsible for key
non-bonding interactions that contribute to a molecule’s overall pharmacological activity. The zoanthamine
alkaloids are an example of natural products that display a variety of biological activities mostly attributed to the
heterocyclic portion of their structures. Notable examples include norzoanthamine with potent anti-osteoporotic
properties, and zoanthenol, which is a selective collagen receptor antagonist for inhibiting platelet aggregation.
The difficulties in synthesizing these architecturally complex alkaloids are apparent in the relative dearth of total
syntheses: since their initial isolation in 1984, only two total syntheses have been reported for norzoanthamine
and one for zoanthenol, all of which are considerably lengthy (40+ steps). This project proposes a total synthesis
for zoanthenol using an aza-Heck/C–C cleavage/cross coupling cascade process to provide an overall
convergent approach to the natural product.
The proposed methodology builds upon precedent established by the Sarpong group in utilizing C–C
cleavage/cross coupling as a strategy for rapidly generating complexity from simple, hydroxylated pinenes. The
addition of an aza-Heck reaction to this overall sequence should provide an avenue for introducing N-
heterocycles onto natural product-like structures. Specific Aim I outlines key considerations for introducing an
aza-Heck reaction to the C–C cleavage/cross coupling sequence, and identifying O-acyl oximes as a versatile
precursor for N-heterocycle formation using transition metal catalysis. Specific Aim II then details a total synthesis
of the natural product zoanthenol using the cascade process developed in Specific Aim I as the key coupling
step. This approach should also enable preparations of related derivatives for potential structure-activity
relationship (SAR) studies to fully elucidate the unique bioactivities displayed by the zoanthamine alkaloids.

Public health relevance
PROJECT NARRATIVE The proposed project presents a method for rapidly building complex, nitrogen-containing structures relevant in small-molecule drug synthesis. The methodology developed should enable the total synthesis of natural products and analogues to facilitate the development of safer yet potent treatments for diseases such as osteoporosis.